Increased Intracellular pH Promotes Cancer Cell Behaviors

Project Summary
Constitutively increased intracellular pH (pHi) is common to most cancers regardless of tissue
origin or genetic background. Increased pHi is sufficient to induce oncogenic phenotypes,
including dysregulated tissue growth, dysplasia, and invasive cell migration. pH-regulated cell
behaviors are mediated by changes in the protonation state of pH sensitive proteins, termed pH
sensors. At the molecular level, changes in pHi can alter the protonation state of amino acid
residues with pKa values near neutral, which can markedly affect protein conformation and
function. By changing the protonation of multiple proteins in unison, pHi dynamics can coordinate
complex cell processes. Although understudied, emerging evidence suggests that increased pHi
contributes to tumorigenesis.
In this proposal, we will explore how increased pHi regulates the proto-oncogene Myc, and
determine how autophagic cell death is enhanced under these conditions. Aim 1 will explore pH
dependent regulation of Myc. Over-expression of Myc rescues the size and patterning errors
induced by increased pHi, suggesting decreased Myc abundance or activity. We will identify the
domains in Myc protein that mediate pH-sensitivity, and the effects of increased pHi on Myc
function. We will explore transcriptional effects of increased pHi to determine affected pathways
and molecules. Aim 2 will determine regulation of autophagy at increased pHi. We will test if Myc
directly regulates autophagy in Drosophila tissues using established molecular markers. We will
develop our clonal mammalian cell system to test whether increased autophagy at increased pHi
is conserved, and identify affected proteins. Finally, we will measure autophagic flux in tumors
with dysregulated pHi to test the hypothesis that increased pHi promotes tumor growth via
recycling of cellular building blocks generated by autophagy.
Using our established methods in the genetic model organism Drosophila and in clonal
mammalian cells, we bridge scales from tissue-level phenotypic analyses to individual pH-
sensitive proteins that regulate cancer cell behaviors. Significant outcomes from our studies
include new insights on how pH-regulated cellular behaviors enable tumorigenesis. Our strengths
and experience linking tissue-level phenotypes to individual pH-sensitive molecules permit unique
insights in this under-studied area of biology. Insights into the molecular mechanisms of pH-
sensitive proteins may inform therapeutic approaches to limit tumorigenesis.

Public health relevance
Project Narrative Increased intracellular pH, or a reduction of acid levels inside cells, is an under-recognized hallmark of cancers regardless of the tissue of origin or underlying genetic mutations. The altered chemical environment can cause aberrant activities of select proteins to promotes tumorigenesis. This project will help us understand how proteins are regulated by acid levels, and how this contributes to tumor growth.